Support of the North American Association of Central Cancer Registries, Inc. (NAACCR) Annual Scientific Conference

Cancer surveillance data are the lynchpin of the cancer data ecosystem. Only through the collection of accurate, standardized, curated data on every cancer patient in the U.S. can we truly monitor and evaluate our progress against cancer. The goal of this application is to convene annual conferences that will strengthen collaboration between the cancer surveillance community and cancer researchers to maximize the impact of cancer registries in advancing our scientific understanding. NAACCR has hosted the most influential and informative annual conference for cancer surveillance scientists in North America for over 30 years. It is the largest meeting of its kind for population-based cancer registries to participate in the advancement of cancer surveillance data science, learn new techniques, exchange information, and develop efficient and cost-effective work practices. This year, renowned speakers and surveillance experts will highlight changes in cancer care, data sources, technology, and research requirements and focus on integrating with cancer surveillance so as to make cancer registries more useful and accessible to researchers. The objective of this conference grant is to: Convene a conference for cancer researchers, NAACCR members and the cancer surveillance community to demonstrate the utility and value of cancer surveillance data in a wide array of cancer research applications, including cancer control, cohort matching through the NAACCR Virtual Pooled Registry, clinical surveillance, pharmacoepidemiology, and population-based site-specific prognostic indicators. Cancer surveillance data forms the backbone of countless cancer research studies each year. The methods used will be the planning and implementation of a world-class scientific conference, with workshops, break-out sessions, panel discussions, keynotes, plenaries, and posters.
The NAACCR meeting is the only cancer surveillance meeting that draws participation from every state and province in the U.S. and Canada.

Public health relevance
For more than 35 years, NAACCR has hosted the most influential and informative annual scientific conference for cancer surveillance professionals. Drawing from every state and province in the US and Canada, as well as international colleagues, the NAACCR Annual Conference is attended by over 350 researchers, epidemiologists, and cancer surveillance scientists annually. Developed by and for cancer surveillance professionals, it is the largest meeting of its kind to share research findings, develop innovative methodologies, support cancer research, and ensure a community that is well-informed on advances in cancer care, data sources, technology, and research interests.